Linking Disease Mechanisms and Outcomes in Rheumatic Diseases

PROJECT SUMMARY/ABSTRACT
Mentorship has been identified as a critical facilitator for development of clinical research faculty. This K24
application seeks to provide protected time for the applicant to continue to mentor numerous trainees in patient-
oriented research (POR) and to grow her current program in new directions to further expand opportunities to
mentor in this arena. 30% of the applicant's effort will be protected by this award for these activities. The applicant
has demonstrated significant abilities in mentoring trainees at all career stages and will continue to benefit from
the rich and robust institutional environment that provides stellar research infrastructure and a large pool of
patients and mentees to work with.
During the funding period, further development of the applicant will include 1) Improvement in mentorship skills
in POR; 2) Enhancement of biostatistics for POR; and 3) Construction of a collaborative niche for POR in pain
in rheumatic disease. These skillsets will be achieved through a combination of seminars, meetings, courses,
and collaboration with the U of M Chronic Pain and Fatigue Research Center and the U of M Fibromyalgia Center
of Research Translation (CORT). In addition, these skillsets will integrate and grow through continued
mentorship of trainees within currently funded POR and through expansion into pain research through the K24
mechanism. These research opportunities include: work that examines the biology of lupus skin in the context
of patient presentation and disease phenotype (Project 1); A clinical trial examining the impact of microbial
colonization on lupus skin inflammation (Project 2); A large, novel immunophenotyped cohort of lupus and
psoriasis/psoriatic arthritis patients that provides large scale datasets for analysis and clinical correlation (Project
3) and; A new dataset collected to longitudinally map chronic pain and sensory sensitivity in patients with
systemic lupus (Project 4). Successful completion of this award will result in successful mentoring of current and
future mentees in POR and also enlarge the POR program of the applicant to ensure continued mentoring
opportunities into the future.

Public health relevance
PROJECT NARRATIVE The goals of this K24 application are to support Dr. Kahlenberg’s continued development as a mentor and to sustain and expand a successful research training program for Patient-Oriented Research (POR) through an interdisciplinary translational research program which focuses on disease mechanisms and outcomes in rheumatic diseases. The awarding of the K24 Mid-Career Investigator Award would ensure that the candidate has significant time for mentoring current and future mentees and securing funding to support her research program. Discoveries supported by and mentees supported through this research are directly relevant to the NIH’s mission to foster fundamental discoveries and their applications to protect and improve public health.